Chd8-dependent molecular and functional vulnerabilities in developed cerebellar limbic circuits

The varied and complex symptoms of neurodevelopmental disorders (NDDs) present significant challenges for
the development of effective treatments. To provide targeted interventions, an understanding of neurobiological
etiology is imperative. Studies have uncovered strong single gene risk factors for NDDs, prominent among
which are genes coding for chromatin remodelers. The chromatin remodeler CHD8 has emerged among such
genes with one of the highest frequency of de novo mutations in ASD cohorts. Intriguingly, CHD8 mutations
have also been discovered in other neurological disorder cohorts, including schizophrenia and obsessive
compulsive disorder (OCD). Thus, CHD8 represents a model for rare monogenic NDDs, with a common core
set of symptoms associated with ASD, but overall broad and complex expressivity spanning early development
through adulthood. Various Chd8 mouse models have been generated, with constitutive mutants exhibiting
NDD-relevant phenotypes. However, in these models the wide expression of Chd8 and its involvement in early
development have hampered dissociation of developmental effects from effects on mature neurons. Moreover,
experimental emphasis on the cerebral cortex and hippocampus has limited advancement from genetic
findings to causal neurobiology. The cerebellum (CB) has been consistently and causally associated with
NDDs, including in emerging studies of developmental roles of Chd8, and has been implicated in
schizophrenia and OCD. Even though roles of the CB have expanded from a motor control center to include
cognitive and affective (i.e., limbic) functionality, CB non-motor contributions and pathology remain
understudied in neuropsychiatric and NDD research compared to forebrain regions. Further, CB studies in
NDDs have primarily investigated developmental impacts. However, Chd8 expression persists in the adult CB.
This raises the novel hypothesis that conditional Chd8 deletion in the adult CB contributes to neuropsychiatric
and NDD-relevant pathology. Here we propose initial work toward testing this model, defining the impact
of conditional Chd8 ablation on adult CB function across behavioral, genomic and electrophysiological
dimensions. In two aims, we will manipulate Chd8 expression in CB output nuclei and test CB-specific
vulnerabilities in limbic behaviors; investigate CB transcriptomic phenotypes; and begin to probe pathology in
the functional connectivity of CB output circuits to the limbic system. These experiments will establish impacts
of conditional Chd8 ablation on the developed CB and output circuits; pinpoint molecular underpinnings of CB
dysfunction; and begin to build a circuit-level understanding of how Chd8 ablation impacts CB connectivity with
the rest of the brain. If successful, this work will lead to new avenues of research on CB dysfunction in NDDs
by linking a high confidence risk gene with behavioral, cellular, molecular, and circuit deficits in the CB. By
pinpointing biological processes and circuits that remain vulnerable to Chd8 ablation in the developed CB, this
line of research has the potential to identify novel therapeutic targets over a time-extended treatment window.

Public health relevance
NARRATIVE Human genetic studies have revealed robust links between epigenetic regulators and complex disorders, such as autism, schizophrenia and obsessive compulsive disorder, but knowledge of the mechanistic basis of these links continues to elude us. Here, we seek to understand the impact of mutations in the risk candidate gene Chd8 on cerebellum-specific neuropathology. This work will offer insights into novel causal contributions of Chd8 and cerebellar circuits to high-order non-motor functions and complex mental health disorders, inform future biomarker development, and can ultimately reveal new molecular and circuit targets for intervention.